Yale Neuroscience Summer Scholars Program

ABSTRACT
Despite the rising number of undergraduate neuroscience majors in the US, only a small fraction of these
students are from under-represented minority (URM) populations. In New Haven Public Schools, a
socioeconomically disadvantaged district surrounding Yale University in Connecticut, over half of students are
URMs and less than 64% of New Haven public high school students attend college within one year after
graduation. Despite the many university, industry, and clinical jobs available in New Haven and the surrounding
area, few New Haven students pursue careers related to neuroscience. In 2010, a college scholarship and career
development program called New Haven Promise was created with funding from Yale University to address
financial barriers to college attendance. Yale provides $5 million per year in scholarships for New Haven public
high school students who meet certain grade point average, attendance, and volunteer requirements. To
encourage New Haven public school students to consider careers in Science, Technology, Engineering, and
Math (STEM), Yale's Office of New Haven Affairs launched the Pathways to Science program, which provides
over 150 free STEM-focused enrichment programs each year for students in middle school through high school.
However, there is currently no formal route for students to obtain hands-on experience that will prepare them to
pursue neuroscience related college degrees and research careers. Building on the strengths of these successful
programs and addressing the unmet need, we propose to establish the Yale Neuroscience Summer Scholars
(YNSS) Program. YNSS will provide research experiences in neurodegeneration, neuroinflammation, and
neuroscience for high school students from New Haven Public Schools, which consist primarily of URM and
economically disadvantaged populations. Rising high school juniors and seniors ages 16 and older will be
recruited through the Yale Pathways to Science outreach program. Each summer, a cohort of four Summer
Scholars will participate in an 8-week session that includes didactics, hands-on training in laboratory techniques,
and completion of a supervised research project. Scholars will participate in scientific writing workshops and
receive instruction on course selection and preparation for applications to college science programs. They will
gain experience in reviewing scientific literature, conducting laboratory research, and writing and presenting
research findings. Aim 1 will develop each participant's foundation in neuroscience through didactic training and
demonstrations on brain anatomy, function, and pathology. Aim 2 will engage each participant in the full spectrum
of laboratory-based neuroscience research, from conducting experiments through collecting and reporting data.
In Aim 3, we will instruct participants in aspects of competitive college application development focused on
applying for scientific majors in neuroscience and related fields. The YNSS Program will apply a holistic approach
designed to provide high school students from an under-resourced community with research experience,
understanding of neuroscience career options, and a clear path to the next step in their educational journey.

Public health relevance
PROJECT NARRATIVE The Yale Neuroscience Summer Scholar (YNSS) Program will provide research experiences in neurodegeneration, neuroinflammation, and neuroscience for high school students from New Haven Public Schools, which consist primarily of underrepresented minority (URM) and economically disadvantaged populations. The YNSS Program will apply a holistic approach designed to provide high school students from an under-resourced community with research experience, understanding of neuroscience career options, and a clear path to the next step in their educational journey.